Generation and validation of antibodies and antibody-based biosensors for the zebrafish research community

Project Summary
Zebrafish are a powerful model system for biomedical research that offers many advantages over other animal
models. The tiny freshwater fish are relatively inexpensive to maintain, easy to breed in large numbers, and
their embryos are transparent, which makes them highly amenable to non-invasive microscopic imaging at
single cell resolution. Furthermore, the development of approaches to genetically manipulate zebrafish has
rapidly accelerated this model system’s utility and contribution to research breakthroughs, including those
uncovering molecular mechanisms driving human diseases. Despite these numerous advantages, research
progress using zebrafish as a model system has suffered from the lack of available, reliable, reproducible,
molecularly defined antibodies targeted to zebrafish proteins. As a result, mechanistic cell biological and
biochemical studies are often incomplete or missing from zebrafish studies leading to incomplete mechanistic
characterizations of proteins and processes and overall reduced reproducibility and rigor in zebrafish research.
To address these problems, we have developed low-cost, accessible tools and methodologies to design and
produce recombinant monoclonal antibodies from primary sequences using high growth density suspension
culture cells. In addition, we developed strategies to diversify recombinant antibodies to generate new products
including species specificity variants and genetically encoded scFvs (single chain variable fragments, or
nanobodies), which can be used as biosensors in living cells. In Aim 1, we will develop, characterize, and
validate recombinant antibodies against zebrafish proteins whose sequences are invariant and molecularly
defined. We will also generate species variants of each antibody to increase experimental flexibility. In Aim 2,
we will develop scFv-based biosensors for select zebrafish target protein post-translational modifications.
These biosensors, which will be genetically encoded and fluorescently-tagged, are ideal tools for real-time
tracking of post-translationally modified epitopes in living cells and whole organisms. In Aim 3, we will build,
maintain, and promote an online resource to provide information, protocols, and reagents produced from this
resource grant. This will serve as the portal to supply antibodies at cost to the zebrafish community and to
provide protocols and reagents to labs that wish to produce their own recombinant antibodies. By combining
complementary expertise from two laboratories (PI Ramani Ramchandran, PhD – zebrafish model expert,
Medical College of Wisconsin; and PI Jennifer DeLuca, PhD – antibody engineering expert, Colorado State
University), we aim to generate a publicly-available library of high-quality, validated, cost-effective, and
immortal source of antibodies to the zebrafish community, which will significantly increase rigor, reproducibility,
sustainability, and accessibility in zebrafish research.

Public health relevance
Project Narrative The goals of this project are to develop, produce, and distribute molecularly defined, invariant, high- quality, immortalized antibodies and nanobodies targeted to zebrafish proteins. The zebrafish model system has become an instrumental component of biomedical research that aims to not only uncover fundamental biological mechanisms but to also develop therapies for a range of human diseases including cancer, cardiovascular and metabolic diseases, and neurological pathologies. The development of the critical resources described here will undoubtedly increase rigor and reproducibility in animal model research and accelerate research progress in the zebrafish field.